Regulation of long distance enhancer-promoter interactions by promoter-proximal elements

SUMMARY
Tight regulation of gene expression in space and time is necessary for development and homeostasis in
multicellular organisms. Regions of the genome outside gene coding sequences (cis-regulatory modules, or
CRMs/enhancers) serve as assembly platforms for transcription factors that facilitate gene expression in
response to cellular or environmental cues. Although many genes are regulated by multiple CRMs,
mechanisms that coordinate the action of these CRMs and that regulate their local chromatin dynamics are
poorly understood. In the fruit fly Drosophila melanogaster, expression of the transcription factor Brinker (Brk)
is activated in the early embryo by two distal CRMs, one 5’ and one 3’ to the brk gene. Initially thought to be
redundant, these CRMs were found to drive sequential, partially overlapping patterns of expression along the
embryonic dorso-ventral axis. Further, these CRMs depend on a promoter-proximal element (PPE) that
appears to facilitate the sequential, long-range interaction of each CRM with the promoter. We have additional
evidence that the brk PPE is required for brk expression in several other tissues. We hypothesize that this
PPE located upstream of the brk gene in Drosophila represents a general mechanism for coordinating
multiple cis-regulatory modules’ (CRMs’) interaction with the promoter, and that this coordination of local
chromatin dynamics is important for proper gene expression, development and maintenance of homeostasis.
To test this hypothesis, we propose the following experimental directions: Aim 1 will test the idea that the brk
PPE manages chromatin conformation at the brk gene locus; Aim 2 will identify molecular effectors
supporting brk PPE action; and Aim 3 will investigate a role for one PPE-binding protein Odd paired (Opa) in
supporting global CRM-promoter interactions at other loci in addition to brk. Many genes across diverse taxa
are regulated by multiple CRMs – including so-called super, stretch or shadow enhancers – yet we know very
little about how these various regulatory contributions are coordinated during normal development. Insights
will come from the study of already well-characterized genes such as brk, whose expression depends on
CRM coordination by a promoter proximal element; as well as through whole genome assays of chromatin
conformation to uncover the mechanisms regulating CRM/enhancer-promoter interactions, in general. New
experimental approaches, which permit targeted manipulation and direct observation of chromatin in live,
differentiated cells of an intact organism, combined with tried-and-true techniques for the analysis of genetic
and developmental phenomena in Drosophila can provide a link between CRM-promoter interaction and the
contributions of transcription factor binding to the regulation of gene expression. Because many genes,
pathways and regulatory mechanisms are shared between Drosophila and higher organisms, improved
understanding of how gene regulation is coordinated at complex loci in flies is likely to inform new approaches
to understand these phenomena in wild-type as well as disease-relevant human contexts.

Public health relevance
NARRATIVE The proposed research plan will provide a link between enhancer-promoter interactions and the contributions of transcription factor binding to the regulation of gene expression. Robust descriptions of these events, in fixed and live cells of the differentiating Drosophila embryo and ovary, will give insight into the inner workings not only of eukaryotic cells generally, but also into the still poorly understood role of regulatory DNA and chromatin architecture relating to dysplasia and diseases; mutations in non-coding loci have been repeatedly implicated in their occurrence. Because many genes, pathways and regulatory mechanisms are shared between Drosophila and higher organisms, improved understanding of how complex loci are coordinated in flies is likely to inform new approaches to understand these phenomena in wild-type as well as developmental- and disease-relevant human contexts.